How to make a microtubule organizing center

Project Summary: The eukaryotic cytoskeleton is a highly dynamic, yet, at the same time, highly organized
network of protein filaments, the most important being actin and microtubules (MTs). MTs are essential for
defining cellular shape and structure, as well as trafficking membrane-bound vesicles, organelles, and, during
cell division, chromosomes. To perform these functions, the cell must tightly regulate the formation of new MTs
via the process of MT nucleation. Cells primarily regulate MT nucleation by controlling the universal MT nucleator,
the γ-tubulin ring complex (γ-TuRC). To initiate MT nucleation, γ-TuRC is recruited to specialized regions known
as MT organizing centers (MTOCs), where γ-TuRC is activated and spatially oriented so that the resulting MT
has the appropriate polarity. Many of the first discovered MTOCs are also the most complex, including the basal
body, which generates flagellar MTs, and the centrosome, which generates many spindle MTs. These classical
MTOCs are composed of up to hundreds of unique proteins organized into complicated large-scale structures.
This makes them poorly suited to uncover MTOC function: namely, how MTOCs recruit, orient, and activate
γ-TuRC. To will illuminate these three basic principles by investigating γ-TuRC regulation in two model essential,
yet simple MTOCs: in the K99 phase, the vertebrate MT branch site and, in the R00 phase, the nuclear plaque
of model excavate Trypanosoma brucei. I will use a combination of reconstitution experiments and cryo-electron
tomography to uncover how these divergent, model MTOCs use shared principles to regulate γ-TuRC. My results
will both help the research community understand MTOC function, as well as provide new therapeutic avenues
to treat infection by parasitic excavates, an emerging global health threat.
As proposed, this research plan will allow me to successfully pivot from my postdoctoral work with Dr. Petry,
an expert on vertebrate MT nucleation, to establish my own, independent research focus on excavate MT
nucleation and launch as an independent investigator. In addition, I have established a mentor team for the K99
phase of the proposal to train me in key technical areas that I require for the independent R00 phase. First, I will
master a TIRF-based assay pioneered in Dr. Petry’s lab that allows visualization of microtubule nucleation at the
single molecule level. Second, which I will learn cryo-electron tomography, a key technique of my proposal, in
collaboration with world experts Dr. Andreas Hoenger and Dr. Martin Beck. In learning this technique, I will
benefit from my mentorship team of Dr. Petry, Dr. Hoenger, Dr. Beck, and the cutting-edge vibrant structural
biology community at Princeton as a whole. Finally, I have recruited Dr. Chris de Graffenried, an expert in
excavate biology, to serve as a scientific mentor as I transition into this new model system. Through the training
phase of the proposal and beyond, I will learn from my mentor team how to successfully lead a research group
that fearlessly leverages a broad range of techniques and disciplines to answer critical scientific questions, and
will, in the R00 phase, establish this group at a leading U.S. institution.

Public health relevance
Project Narrative Microtubules of the mitotic spindle orchestrate equal segregation of chromosomes during cell division. This work will reveal how mitotic spindles are generated during mitosis in animals and trypanosome parasites. By determining how different species make their spindles, we will better understand not only mitosis, a critical event in the lifecycle of the cell, but also can develop new treatments for parasitic infection.